Latinx Hazardous Drinkers: Evaluating Microaggressions

PROJECT SUMMARY/ABSTRACT
This is an application for a Mentored Patient-Oriented Research Career Development Award (K23) to support
the academic career development of the applicant. The candidate's long-term goal is to become an
independent clinical investigator and leader in the theoretical understanding, treatment, and intervention of
hazardous drinking and anxiety among Latinx persons. The applicant has conducted research on
transdiagnostic processes (predominantly anxiety sensitivity) and their association to health behavior research
(predominately focused on smoking) among non-Latinx White individuals. More recently, the applicant has
engaged in research focused on alcohol use among Latinx individuals as well as minority stress as it relates to
smoking behaviors among Latinx persons. Thus, the applicant proposes to build on her past and more recent
research experience, as well as her clinical training, in mental health and follows a logical, but novel,
progression from prior research and training experiences to development of a new area of expertise in the
design and evaluation of alcohol- and anxiety-related processes among Latinx persons who may be impacted
by minority-related stressors. Mentorship will be provided by a group of exemplar senior investigators and will
foster the candidate's development in this new area of research. The applicant proposes a comprehensive
training plan that includes development in five areas: (1) theoretical and empirical knowledge relevant to
minority stress models in the context of hazardous drinking and anxiety among Latinx adults, (2) advanced
longitudinal research design through Ecological Momentary Assessments (EMA), (3) experiential avoidance
(EA) as a transdiagnostic mechanism, (4) advanced analytic training, and (5) advanced research skills in
research dissemination, leadership, and grantsmanship. Through this funding mechanism, the candidate’s
proposed study aims to: (1) examine the influence of microaggressions (MAs) – brief, subtle forms of everyday
discrimination due to racial/ethnic status – on alcohol use motivation and hazardous drinking, (2) examine the
influence of MAs on anxiety experience, (3) explore the mechanisms underlying these relations by evaluating
the indirect effects of MAs on alcohol- and anxiety-related processes via EA, and (4) explore moderators of
alcohol- and anxiety-related processes, including cultural-specific constructs (e.g., ethnic identity, familisimo,
acculturative stress among 200 Latinx adults who are hazardous drinkers. Moreover, we seek to elucidate if
MAs are distinct from, and more impactful than, non-discriminatory daily stressors and overt racism on the
proposed outcomes. This proposal is conceptualized as a prototypical example of translational research that
can explicate mechanisms from a multi-method framework to enhance our understanding of complex minority
stress and hazardous drinking and anxiety relations and serve as a catalyst for future work in this emerging
domain among a health disparities group. The knowledge and experience gained from this proposal will equip
the candidate with a unique set of skills to advance knowledge in this important but understudied area.

Public health relevance
PROJECT NARRATIVE Hazardous drinking and anxiety co-occurrence among Latinx persons in the United States poses a major public health concern. The proposed research aims to study the potential for microaggressions (MAs) – brief, subtle forms of everyday discrimination due to racial/ethnic status – as a culturally-specific antecedent to maintained and exacerbated alcohol use motivation, hazardous drinking, and anxiety experiences among Latinx hazardous drinkers and explore mediational processes and moderators in the MA-hazardous drinking and anxiety experiences relations that will inform future intervention and prevention efforts for this neglected health disparities group. Moreover, we seek to elucidate if MAs are distinct from, and more impactful than, non- discriminatory daily stressors and overt racism on the proposed outcomes.